Structure and dynamics of bacterial cell wall synthases

PROJECT SUMMARY
The peptidoglycan cell wall is essential for viability and growth in virtually all bacteria, and drugs that interfere
with cell wall assembly are among the most effective antibiotics. Building a peptidoglycan cell wall requires
precise spatiotemporal regulation of glycan strand elongation catalyzed by transglycosylase enzymes and of
peptide crosslinking catalyzed by transpeptidases. Virtually all bacteria require two orthogonal families of PG
synthases to accomplish cell wall assembly: bifunctional aPBPs and SEDS-bPBP two-component enzymes.
Both enzymatic families are essential for growth, making them ideal antibiotic targets. In this project, we will
investigate the molecular mechanisms that underlie enzymatic activation and regulation of these proteins using
a combination of structural biology and single-molecule fluorescence approaches. Specifically, we will investigate
1) how structural dynamics that are central to the activation of SEDS-bPBPs are regulated by their accessory
partners in vivo, and define 2) the mechanistic and structural basis that underlies allosteric activation of aPBPs
by their lipoprotein cofactors. Collectively, these aims will lead to the development of a detailed mechanistic
understanding of essential cell wall synthases, paving the way for future antibiotic discovery.

Public health relevance
PROJECT NARRATIVE The proposed research will investigate two orthogonal families of PG synthases called SEDS-bPBPs and aPBPs, both of which are essential for bacteria to build and repair their cell wall. These proteins are potential targets for the development of new antibiotics, but basic aspects of their function and regulation remain unknown. The work in this project will help to understand how these synthases function to facilitate discovery of candidate antibiotics.